Perivascular Fibroblast-Endothelium Interactions in Hypertension and Cerebral Ischemia

PROJECT SUMMARY (Description)
Perivascular fibroblasts (PVFs) and vascular endothelium are important responders to hypertension and
cerebral ischemia. Long-term aberrant interactions of PVFs and endothelium may also promote vascular
cognitive disorders (VCD), but the mechanisms remain poorly understood. This project will use PVF-specific
single-cell RNA-Seq and vascular endothelium-specific or TRAP-Seq to test the impacts of hypertension and
cerebral ischemia on gene expression. Outcomes of this project may suggest novel therapeutic targets.
Aim 1 will test the transcriptome changes of endothelial cells in a mouse model of chronic hypertension
(ReninTg) with and without partial cerebral ischemia.
Aim 2 will use bitransgenic ReninTg and Pdgfra-H2BGFP mice, with and without partial cerebral ischemia, to
isolate PVFs for single-cell RNA-Seq comparison.
In summary, this project will use open-ended genomic methods to correlate, for the first time, the transcriptome
adaptations by PVFs and vascular endothelium to hypertension and combined hypertension/ischemia.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (Narrative) Hypertension is a major rsik factor for cognitive impairment and small vessel diseases that often co- exist with the Alzheimer-type dementia, but the underlying mechanisms remain poorly understood. This project will use advanced genomic methods to assess the impacts of chronic hypertension plus acute partial cerebral ischemia on the transcriptome of perivascular fibroblasts and vascular endothelial cells. Positive outcomes of this project may shed mechanistic insights into the pathogenesis of hypertension- related vascular injury and cognition impairment.